Therapeutic targeting of MYC interactions with an essential cofactor

MYC is the most frequently amplified gene in human cancer and is overexpressed as a
consequence of mutations in diverse oncogenic signaling pathways in 70% of cancers. Given
the ubiquity of MYC as a driver of cancer, there is a critical unmet need to develop specific
drugs that inhibit MYC function as anti-cancer therapeutics. TRansactivation/tRansformation-
domain Associated Protein (TRRAP) is an essential nuclear cofactor for MYC, and small
molecule inhibitors of the MYC:TRRAP interaction are predicted to have potent anti-cancer
activity. We developed a luciferase-based assay to identify small molecule inhibitors of
MYC:TRRAP and initiated a collaboration with the Novartis Institute for Biomedical Research to
search their non-proprietary 50,000 drug-like compound set. We identified 33 diverse
compounds that show inhibitory activity for MYC:TRRAP in the nanomolar to micromolar
concentration range using our luciferase assay. We propose to use cellular and molecular
assays to determine which of these compounds inhibit native MYC:TRRAP complexes and
ascertain their specificity regarding other MYC and/or TRRAP interacting proteins. Promising
compounds will also be assayed for growth inhibitory activity in triple negative breast cancer
cells, which have high levels of MYC and determine if growth inhibition can be attributed to loss
of MYC function. A long-term goal is the preclinical development of our top lead compounds for
in vivo experimentation.

Public health relevance
Cancer is one of the leading causes of death worldwide, and mutations in the gene called MYC are found in 15-20% of all cancers. MYC is also a driver of cancer cell growth in response to other mutations in cancer cells. The MYC protein functions by binding to DNA and regulating other genes with the help of enzyme complexes containing the essential protein cofactor TRRAP. The goal of this project is to develop drugs that inhibit MYC function by blocking interaction with TRRAP and hence are potential therapeutics for the treatment of cancer.